Immunological characterization of the P. vivax DBP

DESCRIPTION (provided by applicant): Malaria caused by Plasmodium vivax is responsible for substantial morbidity in developing countries, producing 75-90 million cases of clinical malaria each year. Increasing prevalence of drug resistance in P. vivax, its global distribution and the appearance of more virulent forms of vivax malaria emphasizes the need for development of vaccines against this disease. Vivax malaria severely incapacitates infected persons, causing severe anemia, especially in young children, and an increased risk of low-birth-weight babies in pregnant women. Immunity to erythrocyte invasion ligands plays the critical role in controlling the blood-stage infection of P. vivax, since this malaria parasite does not sequester. Only persons that express the Duffy blood group antigen are infected with blood-stage P. vivax. Recognition of this human erythrocyte surface receptor is dependent upon the Duffy binding protein (DBP) cysteine-rich ligand domain, also known as region II or Duffy binding-like (DBL) domain. This essential interaction is a critical weakness in the parasite's life cycle. The major obstacle for developing this antigen as an effective vaccine is its high degree of polymorphism that makes ineffective the normal immune response following infection. Understanding the DBP-DARC interaction provides a model for all erythrocytes binding domains for Plasmodium-erythrocyte interaction. The specific aims will define the immunological and functional properties of the DBP ligand domain and identify functionally conserved determinants of the receptor-binding site that are able to induce a broadly inhibitory antibody response capable of inhibiting blood-stage development of Plasmodium vivax.